Improved Patient Reported Outcomes (iPRO) -Sleep Diary: A Tool to Improve Sleep Assessment in Clinical Trials

Abstract
Insomnia is a highly prevalent condition that significantly degrades the quality of life and health of millions of
patients. By diagnostic definition, insomnia is a disease characterized by self-reported subjective criteria, thus
therapeutic developers targeting insomnia typically evaluate their treatment’s efficacy based on patient reported
outcomes in the form of sleep diaries. A critical flaw with this assessment approach is that self-perception of
sleep is inherently noisy due to the inability of patients to perceive the transition to and from unconscious sleep
and sources of variability related to bias, mood, and other contextual factors. To overcome this limitation, many
clinical trials incorporate clinically validated wearable devices into their trials as surrogate assessments which
are interpreted in conjunction with sleep diary data. Wearable devices are also imperfect tools to assess sleep
because they are similarly limited by non-disease, non-treatment related factors including imperfect operation,
imperfect algorithms, and misuse. Furthermore, numerous studies in clinical and non-clinical populations have
demonstrated that there are significant discrepancies between sleep diaries and wearable device derived sleep
metrics raising the question as to which assessment approach is valid. Without a method to reconcile differences
between sleep diaries and wearable devices the current practice for clinical trials is to rely on sleep diary data
which is suboptimal and may contribute to blunted or nonsignificant effects in trials. The improved patient
reported outcome (iPRO) – Sleep Diary is a method and system designed to improve sleep assessment by
combining sleep diary and wearable device data while maintaining the subjectivity of sleep assessment. The
proposed solution is to provide patients their wearable device-derived sleep data contemporaneously with the
completion of the sleep diary. The patient reported sleep diary measurement is still the outcome of interest,
however patients have the freedom to incorporate or disregard their objective data in their assessment. This
approach is inspired by signal processing theory where measurements from two sensors with uncorrelated
sources of error (sleep diary and wearable device) are combined to improve the measurement of the underlying
signal. The approach of providing patients their objective data and then using their sleep diary response (in
contrast to averaging) is used to preserve patient autonomy and leverage the benefits of self-reported data.
Preliminary data suggest the iPRO-Sleep Diary non-linearly improves measurement precision of sleep metrics
and reduces discrepancy between device and sleep diary data. This platform technology is expected to improve
the assessment of sleep in clinical trials and enable more efficient development of effective therapeutics.

Public health relevance
Project Narrative Insomnia is a highly prevalent disorder with significant health and economic impacts. Unfortunately, the development of therapeutics for insomnia is hindered by suboptimal sleep assessment in clinical trials. This project proposes to further develop the improved patient reported outcome (iPRO) - Sleep Diary, a platform technology, to improve sleep assessment and to optimize therapeutic development for insomnia.